Preclinical Assessment of Phage Therapy for Pathogen Decolonization

To develop animal models for studying the use of bacteriophage therapy to decolonize or treat MRSA and VRE, antibacterial resistant infections.